Core C - Bioinformatics and Biostatistics Core

Project Summary
During the past quarter decade, the rapid expansion health information through the institution of electronic
health records, the implementation new technologies for large-scale generation of multi-omic and imaging data,
and development of new statistical and computational methodologies for cancer research has led to a
recognition of the critical need for participation of quantitative scientists in the research process and a higher
standard for what constitutes acceptable scientific evidence in a study. The GI SPORE will conduct large-scale
studies and generate substantial quantities of complex biological and biomedical data. Ensuring that the
SOPRE's research projects arrive at robust and statistically significant conclusions. The Biostatistics and
Bioinformatics Core includes leading quantitative research scientists who will work with SPORE personnel to
assure that the research carried out meets the prevailing and emerging research standards and adapts as new
technologies develop and are introduced into the scientific research program. This support will be provided by
establishing, maintaining, and supporting collaborative relationships that will ensure that Core members are
integrated members of the research teams and provide appropriate statistical and computational support for all
GI cancer SPORE investigators. This will include consultation and collaboration on all aspects of study design,
database development and quality control, and analysis and interpretation of data.

Public health relevance
Project Narrative The Biostatistics and Bioinformatics Core will provide support for the research mission of the GI SPORE by assisting the members of the Programs and other Cores in the design of their experiments and the analysis and interpretation of the resulting data. The Core personnel represent leading experts in biostatistics and bioinformatics and will use modern, advanced methods to assure the conclusions emerging from the SPORE are robustly supported by the underlying data.